4D MOUSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Keywords: Volume data analysis, visualization and distribution, collaboration Abstract: Johnson's group has collected a number of gated micro-CT studies on the mouse cardiac cycle, including the effect of number of scans and the amount of dye given to the mouse. In order to analyze this data, the PSC volume browser will be modified to allow for the efficient viewing of 4D (3D volumes varying over time) and the ability to support analysis tools as plug-ins, server-side modules, and as stand-alone packages.